Developing robust genome editing tools for generating floxed alleles and editing amino acid change in zebrafish

PROJECT SUMMARY/ABSTRACT
Zebrafish provide a valuable model system for studying developmental and regenerative biology.
Recent advancements in genome editing techniques enable the generation of knock-out alleles in
zebrafish, expanding the usefulness of this model organism to interrogate loss-of-function study.
However, the majority of genome editing-mediated mutants in zebrafish consist of conventional loss-
of-function mutants rather than more sophisticated alleles, such as conditional loss-of-function alleles.
Thus, a critical obstacle in zebrafish research lies in the functional dissection of genes within specific
cell types and during later development stages. A reliable and definitive conditional loss-of-function
system that has been utilized extensively in other organisms is Cre/lox-mediated gene disruption.
Although this Cre/lox system is functional in zebrafish, creating reliable floxed alleles has remained
challenging. This proposal aims to address the existing limitations in conditional genetics within the
zebrafish model by developing a robust and effective methodology. In Aim1, we will establish a
synthetic exon-mediated integration approach, allowing the addition of two loxp sites into the target
gene within a single generation. We will compare our strategy with the previously published method to
assess efficiency. Our study will establish the effective method to generate reliable floxed alleles.
Combined with CreER lines, these floxed alleles will enable conditional knock-out of target genes at a
predefined time and/or in discrete cells, facilitating investigation of intricate cellular and molecular
mechanisms. Advancements in base and prime editing techniques enable to introduce human disease-
causing mutations into the zebrafish genome, significantly promoting the application of zebrafish for
human disease modeling. However, the current base and prime editing approaches rely on PCR-based
screening to identify lines carrying the edited genome. Given the low efficiency of base/prime editing
and a reduced germline transmission rate, the current screening method may fail to select positive fish
due to the complicated multiple steps for genotyping. In Aim 2, we will expand our synthetic exon-
mediated genome editing approach to develop a proficient and highly effective method for editing amino
acid changes in zebrafish. We will combine a synthetic exon approach with a robust fluorescence-
based screening strategy to dramatically reducing screening effort for introducing amino acid change.
Overall, our methods, lines, and reagents will save years of research time in developing diverse
zebrafish genetic models that can open new research avenues within the zebrafish community.

Public health relevance
PROJECT NARRATIVE Genetically modified zebrafish serve as essential tools to study fundamental biology and to model human diseases. This project will develop a highly efficient methodology to establish valuable genetically modified zebrafish models, thereby broadening our understanding of disease mechanisms and facilitating identification of new therapeutic targets.